SAFETY/EFFICACY OF COMBINATION 1592U89/ZDV/3TC VERSUS ZDV/3TC IN HIV CHILDREN

This study will compare the durability of viral load response following 48 week treatment w/1592U89/ZDV/3TC vs. ZDV/3TC, assess the safety and tolerance of these combinations. It will also compare the clinical efficacy of the two regimens as determined by survival, disease progression, weight velocity and neuropsychological or neurological changes, assess the viral resistance in a subset of subjects, characterize the steady-state plasma levels of 1592U89 across the subjects between 3 months to 13 yrs of age, evaluate the changes in drug pharmacokinetics.